TRIAL OF IRINOTECAN IN PTS WITH ABNORMAL LIVER/RENAL FUNCTION OR PRIOR PELVIC RAD

This study is determining a tolerable dose of irinotecan in patients with ranging degrees of liver or renal dysfunction or prior pelvic radiation, and characterize the pharmacokinetics.